Data Science Core

PROJECT SUMMARY (DATA SCIENCE CORE)
Advancing multidisciplinary biomedical research is significantly enhanced when there is support for
rigorous experimental design, analysis, and management of the increasingly vast datasets generated. The
UNH COBRE: Center of Integrated Biomedical and Bioengineering Research (CIBBR) substantially advanced
the biomedical research infrastructure at UNH during Phase 1 by significant CIBBR investments in state-of-the-
art instrumentation, augmented by additional institutional investments in high-throughput molecular diagnostic
screening and genomic sequencing capacity at the Hubbard Center for Genome Studies (HCGS). These
enhanced opportunities for multidisciplinary research collaborations and scientific training opportunities in
biomedical and bioengineering research catalyzed by CIBBR are now aligned with institutional commitments in
Phase 2 to conduct a cluster hire of early-career and senior-level researchers focused on the areas of
quantitative/computational biology and multi-omics.
During Phase 1, UNH invested significant computational resources in the Research Computing Center, and
together with the HCGS established effective support for bioinformatic needs. However, important gaps persist
in biostatistical support services (including experimental design and implementation) as well in the
management and sharing of large multi-omics datasets. The objective for the Data Science Core (DSC) is to
enable researchers to adopt multi-omics technologies to enhance opportunities for rigorous, multi-disciplinary
research programs by: (1) providing a comprehensive support infrastructure for data analytics throughout the
entire data life cycle, thereby addressing the increasing need for statistical analysis and management of data
generated by multi-omics technologies; (2) promoting the FAIR principles of data science by implementing best
practices for data management and deposition; (3) creating training opportunities needed to support best
practices in Data Science; and (4) implementing a business plan to ensure the long-term sustainability of the
DSC infrastructure at UNH.
Establishing a DSC that combines a full range of biostatistical and bioinformatics support services,
management of computational resources (including support for cloud computing), and provision of training
workshops will have a major positive impact for CIBBR investigators, the UNH research community, and our
IDeA-state collaborators. By supporting innovative data analytics approaches necessary for multidisciplinary,
multi-omics research that enhance rigor and reproducibility, the CIBBR DSC will become an indispensable
core facility offering a unified and critical set of support services to advance biomedical and bioengineering
research capacity at UNH.